Treatment of Periodontitis by Homing M2 Macrophages

Periodontitis (PD) is the second most common oral disease, affecting about half of adults (65 millions) in the
United States. Periodontitis causes tooth loss and has been implicated in the pathogenesis of several serious
systemic diseases including diabetes, cardiovascular diseases, and premature birth. Periodontitis is a chronic
inflammatory disease, triggered by bacterial infection present in dental plaques and calculus; but actual disease
manifestations are caused by host immune response to these pathogens. Current standard treatment is
debridement of plaques and calculus to reduce the bacterial load; however, there are no therapies that address
the immune component of PD. Thus, many research groups have started developing technologies to regulate
the immune response and reduce inflammation. Our group has focused on recruiting and polarizing M2
macrophage as novel approaches for therapy of periodontitis. In our previous study, we successfully prevented
alveolar bone loss by locally inducing M2 macrophages in mouse periodontitis models. M2 macrophages were
polarized by injecting C-C motif chemokine 2 (CCL2) releasing PLGA microparticles (MPs) into periodontal
tissues. The results indicated that inducing M2 macrophages by local delivery of CCL2 indeed reduces
inflammation and bone loss in periodontitis. The proposed study will explore further the therapeutic potential of
M2 macrophage induction by CCL2 as well as shed light on the mechanism underlying this process. We
hypothesize that CCL2 plays a key role in maintaining periodontal immune homeostasis, and that its exogenous
delivery, or genetic ablation, would modify the course of PD through periodontal breakdown, repair and
microbiota dysbiosis. Macrophages play an important role in both the destructive and constructive phases of
the inflammatory response by modulating their ability to polarize into either M1 (pro-inflammatory/pro-destructive)
or M2 (anti-inflammatory/pro-reparative) macrophages. Our hypothesis is strongly supported by our recent in
vivo data showing that the local delivery of CCL2 will induce differentiation of macrophages and monocytes to
an M2 phenotype, thus leading to decreased periodontal inflammatory bone loss and initiation of periodontal
repair. To test this hypothesis, we propose the following specific aims: 1) To test CCL2 MPs as an interventional
and reparative periodontal therapy; 2) To study the periodontal phenotype, periodontal breakdown and repair in
CCL2-knockout mice (CCL2-KO); and 3) To perform Single cell RNA sequencing (ScRNA-Seq) to acquire in-
depth mechanistic data about the role of CCL2, its association, effect on and interactions with other immune
cells. We anticipate that CCL2 released from PLGA MPs will inhibit further bone loss and promote repair in the
mouse periodontitis model. We also expect that CCL2-KO mice and ScRNA-Seq analysis will provide data critical
to understanding underlying mechanisms of CCL2’s immunoregulatory effects. In sum, we believe that M2
macrophage induction by CCL2 in inflamed periodontium could be a novel, promising strategy for treating PD.

Public health relevance
Project Narrative This study is relevant to the public health because large population (half of adult population) is affected by periodontitis, and the methods used in this study can be easily translated to noninvasive clinical treatment. In addition, this study will establish the efficacy of recruiting and differentiating macrophages to M2 macrophages which could also be used as a treatment to other chronic inflammatory diseases.